A controlled evaluation of abstinence-induced withdrawal and motivation to vape/smoke among daily ENDS users vs. cigarette smokers

Project Summary
Despite the importance of smoking withdrawal symptoms (e.g., craving, negative affect, disrupted cognition)
for understanding tobacco/nicotine dependence and elucidating intervention targets, the parent study is the
first-ever prospective, controlled comparison of abstinence-induced withdrawal between people who use
electronic nicotine delivery systems (ENDS) and those who smoke cigarettes. However, like most research in
the field, we currently exclude people with schizophrenia (SCZ). Lack of representation of people with SCZ is a
major problem in nicotine/tobacco research, contributing to greater tobacco-related health disparities than
perhaps any other population segment, with extremely high rates of use and low rates of cessation, which
contributes to a marked excess in morbidity and mortality. A burgeoning literature is examining ENDS as a
harm reduction approach to tobacco smoking. However, there are major concerns with this direction of
research, particularly for people with SCZ. Though ENDS appear much less harmful than cigarettes, they still
carry neuropsychiatric and cardiovascular consequences, and research on interventions for vaping cessation is
in its infancy. Indeed, the addiction liability of ENDS in people with SCZ is unknown. It is critical that we
understand how withdrawal from ENDS compares to that of cigarettes. Notably, results from the general
population (like the parent study) may not generalize to SCZ as they may be more vulnerable to ENDS
dependency and experience different or more severe withdrawal due to multiple disease-related factors. The
proposed supplement leverages the strengths of the parent study, which focuses on the general population, and
enhances its overall project impact and relevance to health disparities by recruiting a sample of people with
SCZ, half of whom vape ENDS daily and half of whom smoke daily. The supplement will provide novel data on
the effects of 24-hr abstinence from vaping vs smoking on self- report and objective assessments of major
facets of withdrawal in people with SCZ, as well as changes in neuropsychiatric symptoms. It will also provide a
novel comparison of vaping/smoking withdrawal in people with SCZ (the supplemental data) to a matched
group of people without SCZ (from the parent trial) and explore candidate moderators (e.g., antipsychotic
class, sex). Results will provide the first literature on ENDS withdrawal in people with SCZ, who continue to be
an under-represented group in nicotine/tobacco research, despite their facing marked tobacco-related health
disparities (a NIDA strategic plan cross-cutting theme). Results will directly inform the suitability of ENDS for
tobacco harm reduction (NIDA strategic plan priority area #2) in people with SCZ. Moreover, the
comprehensive, multi-modal assessment of withdrawal facets will directly inform the development of ENDS
cessation interventions for people with SCZ.

Public health relevance
Project Narrative Despite people with schizophrenia (SCZ) facing marked tobacco-related health disparities, most smoking/vaping behavioral pharmacology studies and clinical trials exclude people with SCZ. Indeed, although withdrawal is considered a key feature of nicotine/tobacco addiction that contributes to difficulty quitting smoking and likely electronic nicotine delivery systems (ENDS; e.g., electronic cigarettes), there is currently no research on ENDS withdrawal in people with SCZ. The proposed supplement will extend the parent study’s systematic and comprehensive characterization of withdrawal (in a general population sample) to people with SCZ who vape daily compared to those who smoke daily, filling critical gaps in our understanding of ENDS dependence liability for people with SCZ and contributing to the identification of intervention targets for ENDS use.